Understanding the role of KDM6B in parturition onset

Project Summary (Abstract)
Preterm birth (PTB) is the global leading cause of death for children under the age of five. In large part, this
high burden results from our limited understanding of the mechanisms controlling normal parturition. In mice,
one parturition pathway involves increased uterine epithelial cell expression of the prostaglandin synthase
COX-1. COX-1 then allows the uterus to produce prostaglandin PGF2α, which turns off progesterone
production by the ovary. How this important enzyme is regulated, however, remains unknown.
This proposal is based upon my unpublished data that epigenetic pathways play a central role in the induction
of COX-1 expression by uterine epithelial cells and hence initiation of the labor cascade in mice. Specifically, I
have found that mice engineered to lack uterine expression of KDM6B, a histone H3K27me3 demethylase,
show delayed parturition associated with reduced COX-1 expression by luminal epithelial cells. Motivated by
this data, my two Specific Aims will seek to identify (1) the cellular and molecular circuitry and downstream
events through which KDM6B induces parturition; and (2) the upstream regulators of KDM6B activity. Results
from these studies will provide clear cellular and molecular definition to a key regulatory circuit that initiates
parturition in mice, potentially including the identification of epigenetic components of the long-mysterious
gestation length “timer.” As such, they might open new avenues for dissecting the mechanisms of human
parturition and for determining how such mechanisms are dysregulated in human pregnancy complications like
preterm birth.

Public health relevance
Project Narrative The rate of preterm birth continues to rise in most industrialized countries and remains the global leading cause of perinatal morbidity and mortality. In large part, this high burden results from the limited understanding of the mechanisms controlling the timing of normal labor. The proposed research delineates a novel, epigenetic pathway required to initiate parturition and thus identify effective strategies for preventing or treating preterm birth.